Characterizing the role of confirmation bias in financial exploitation of older adults

PROJECT SUMMARY/ABSTRACT
Confirmation bias refers to the tendency to interpret new information in a way that conforms to one's pre-existing
beliefs. It is associated with deficits in cognitive functions like working memory and error detection, both
commonly associated with the prefrontal cortex (PFC). As such, age-related changes to the PFC may leave
older adults vulnerable to this bias and its negative outcomes, including financial exploitation. Older adults are
disproportionately impacted by financial exploitation, and as cognitive decline progresses to mild cognitive
impairment (MCI) and Alzheimer's disease and related dementias, risk for fraud increases. Given these
connections, confirmation bias may serve as an indicator of cognitive decline and vulnerability to fraud; however,
progress towards understanding these relationships has been hampered by three main issues. First, little is
known about the latent processes shaping confirmation bias in older adults. Second, much of the work to date
has relied on correlations between brain responses and behavior, leaving the causal mechanisms unclear. Third,
behavioral changes over time in this population are underexplored. To address these concerns, this project has
two specific aims. The first is to characterize how age-related differences in cognitive function contribute to
susceptibility to confirmation bias. In an online study, participants will play an investment game involving the
opportunity to update an initial judgment after receiving feedback from a partner (Aim 1). We hypothesize that
older adults showing cognitive decline will exhibit confirmation bias at higher rates than younger adults,
characterized by greater bias towards initial judgments and decreased engagement with conflicting feedback
from the partner. Our second aim is to assess the causal relationship between confirmation bias and the PFC in
older adults using transcranial alternating current stimulation (tACS; Aim 2). By applying tACS to the PFC, we
will entrain individualized theta rhythms to enhance function across the region. Using the investment task from
Aim 1 concurrent with tACS, it is hypothesized that confirmation bias will be diminished in older adults, particularly
among those with MCI. Finally, to fully characterize the predictive role of confirmation bias, we will follow up with
participants after two years to assess the progression of cognitive decline. It is predicted that higher rates of
confirmation bias at visit one will be associated with greater cognitive decline at follow-up. The funding from this
grant will provide the applicant with the opportunity to learn essential new skills in computational modeling (Aims
1 & 2) and noninvasive brain stimulation (Aim 2). These objectives will be accomplished through a combination
of workshops, expert mentorship, and institutional training. Overall, this project will leverage training in well-
established and cutting-edge techniques to help expand the understanding of cognitive decline and provide
insight into causal links between PFC function and susceptibility to confirmation bias. More generally, it may
provide new insights into reducing older adults' susceptibility to the bias and their risk for financial exploitation.

Public health relevance
Project Narrative Confirmation bias is a ubiquitous phenomenon that can lead to a variety of negative outcomes, including financial exploitation. Age-related differences in the function of the prefrontal cortex, coupled with deficits in cognitive processes like working memory and error detection, may leave older adults particularly susceptible to this bias and its harmful effects. Using computational modeling, noninvasive brain stimulation, and longitudinal methods, we aim to establish a clearer connection between confirmation bias and mild cognitive impairment that will provide insight into ways to mitigate its negative effects and protect older adults from fraud.